Dietary fat-activated colonocyte-macrophage ketone shuttle drives intestinal inflammation

PROJECT SUMMARY
An estimated 3 million US adults suffer from inflammatory bowel disease (IBD), a group of conditions primarily
including ulcerative colitis (UC) and Crohn's disease (CD) and are characterized by chronic or recurring
inflammation of the gastrointestinal tract. While anti-inflammatory and immunosuppressant drugs are available
to control symptoms (remission), the relapsing rate can be as high as 75% and challenges exist to effectively
maintain remission and improve quality of life. Prebiotic fibers and short-chain fatty acids (SCFAs) generally
have beneficial effects on intestinal physiology, and butyrate is the preferred oxidizable fuel for colonocytes. On
the other hand, dietary fat exacerbates experimental colitis, and its overconsumption is associated with the global
increase in the prevalence of UC. The proposed project aims to understand how excessive fat in diet perturbs
colonic metabolism of butyrate and subsequently leads to elevated mucosal inflammation. One notable
alternative fate of butyrate in colonocytes is to generate ketone bodies including acetoacetate (AcAc) and D-β-
hydroxybutyrate (D-βHB). There is a significant knowledge gap regarding the pathophysiological function of
mucosal ketone bodies. In Aim 1, we propose to test the hypothesis that terminal oxidation of butyrate in
colonocytes suppresses while ketogenesis promotes intestinal inflammation. We will first perform stable isotope
tracing experiments to determine butyrate’s fate during colitis. Using genetic mouse models, we will determine
functional outcomes of terminally oxidative vs. ketogenic metabolism of butyrate in colitis. In Aim 2, we seek to
understand how high-fat diet (including ketogenic diet) promotes the colonocyte-macrophage ketone shuttle to
drive inflammation. We will test the hypothesis that the fat-sensitive PPARα signaling, by counteracting the
tissue-reparative type 2 immune response, activates colonic beta-oxidation and ketogenesis to potentiate gut
inflammation. Intestinal macrophages, predominantly derived from monocytes via a “waterfall” differentiation
process, are the gatekeepers of mucosal homeostasis. In Aim 3, we hypothesize that the utilization of locally
produced ketone body, specifically AcAc, induce the formation of Spp1+ macrophages to drive inflammation.
Taken together, we expect to find that dietary fat induces the metabolic switch from butyrate terminal oxidation
to ketogenesis in colonocytes, which reprograms intestinal macrophages to form a pro-inflammatory milieu. The
proposed study will provide valuable insights into the metabolic underpinnings of UC etiopathogenesis and the
development of future therapies and dietary advice for UC patients.

Public health relevance
PROJECT NARRATIVE The increasing prevalence of ulcerative colitis (UC) in westernized societies is associated with the overconsumption of dietary fa; however, our understanding of metabolic underpinnings of UC remains limited. The proposed study will reveal a dietary fat-induced ketone shuttle by which colonocytes use microbial butyrate and dietary fatty acids to generate ketone bodies for the establishment of colitogenic monocytes & macrophages. It will provide a new direction in the future to target ketogenesis for remission maintenance and mucosal healing.